Dissecting the role of long range prefrontal circuits in early-life stress induced susceptibility

My career goal is to become an expert on the circuit level mechanisms of neural
transmission underlying developmental stress and individual differences in stress response and
sensitivity. I plan to lead a research lab studying the neurophysiological mechanisms of early-life
stress (ELS) and the emergence of individual differences in adult stress response. ELS creates
long-term risk to depression and anxiety disorders, particularly after facing stressful
events during adulthood. However, little is known about how ELS produces sustained
changes at the neural circuitry level that increase sensitivity to stress later in
life. This kind of detailed circuit dissection cannot be performed in humans, thus by
using a recently established two-hit model of early-life and adult stress in mice in which stress
during a specific postnatal window increases the likelihood of adulthood stress to
induce depressive-like behaviors. With this K01 grant and under the mentorship of Dr. Rene Hen at
RFMH and Columbia University, I will test the role of long-range prefrontal circuits in the
ELS-induced susceptibility to adult stress. I will combine an established two-hit mouse
model of stress with advanced methods such as multi-site electrophysiological recordings
and intersectional approaches for pathway specific chemogenetic manipulations. These studies
represent a number of firsts in the developmental/systems neuroscience field: 1) the first to
test the role of some of the long-range prefrontal cortex associated circuits
(prefrontal-accumbens, amygdala, ventral hippocampus) activity and communication in stress
susceptibility; 2) the first to dissect neural circuit activity and communication
underlying the ELS-induced changes in adult stress response; 3) the first
to investigate the impact of ELS in stress-susceptibility and underlying neural circuits in
females; 4) the first to combine developmental stress with simultaneous multi-site
recordings and intersectional approaches for pathway specific manipulations. These studies
represent a significant career change and research redirection for me. This K01 award will
afford me the mentorship and additional training that will prepare me to achieve my
career goals and establish an independent research program geared towards investigating the
neural circuits of which ELS leads to lifelong susceptibility to depression and psychiatric
disorders.

Public health relevance
Early-life stress induces sensitivity to stress later in life, and is one of the best-characterized risk factors for developing depression and anxiety disorders. This research proposal will identify the neural circuit activity underlying the early-life stress induced susceptibility later in life in male and females. This work will contribute to a novel understanding of depression susceptibility with the long-term goal of developing novel therapeutic targets.